Trial readiness for LCAT deficiency

PROJECT SUMMARY
Genetic bi-allelic deficiency of LCAT (LCAT-D) is an ultra-rare, autosomal recessive condition that manifests as
two different syndromes, familial LCAT deficiency (FLD) and fish-eye disease (FED). Both syndromes are
characterized by excess of unesterified cholesterol (UC), significantly reduced HDL-C levels and corneal
opacities. In addition, FLD patients develop chronic progressive renal disease, which represents the main cause
of morbidity and mortality in this condition. Additional manifestations of FLD include anemia, increased levels of
triglycerides and the presence of an abnormal lipoprotein called LpX. While the consequences of LCAT-D on
lipoprotein metabolism have been extensively characterized, much less in known about the natural history of
LCAT-D. Clinical presentation and progression of disease appear to be heterogeneous across individuals, and
we still lack a clear understanding of the factors contributing to such variability, not only between FED and FLD,
but also within each syndrome. Current treatment for FLD is limited to symptomatic management of its sequelae.
Novel therapeutics targeting LCAT are at different stages of development, including an AAV-hLCAT gene
therapy approach at the University of Pennsylvania. Unfortunately, their further development is limited by
inadequate understanding of the natural history of LCAT-D. Identification of suitable biomarkers to determine
eligibility and assess efficacy is urgently needed. The overarching goal of this proposal is to: 1. Identify
biomarkers that can guide enrollment criteria, including diagnostic biomarkers to distinguish FLD from FED, and
prognostic biomarkers to enrich enrollment with FLD patients that have a higher risk of rapid CKD progression
(Aim 1). 2. Identify pharmacodynamic and efficacy biomarkers to aid the identification of target response and the
efficacy of the intervention tested (Aim 2). 3. Identify comorbidities and concomitant medications that may impact
pharmacodynamic measurements (Aim 3). We will achieve these goals by performing unbiased retrospective
long-term deep data extraction from medical records of FED and FLD patients that will enroll in our ongoing
natural history study (NCT06217588). These data will be complemented by laboratory assays assessing LCAT
mass and activities, and other markers of esterification, including %CE, done in samples obtained from the
patients enrolled in the study and from pre-existing samples and data from selected cohorts of LCAT-D patients
and patients with secondary LCAT deficiency. The successful completion of this study will provide key diagnostic
biomarkers and needed information on the rate of decline of key markers of disease, as well as the effect of
concomitant medications or co-morbidity that may affect the primary pharmacodynamic parameters. Overall,
these data will be pivotal for the refinement of the inclusion and exclusion criteria and be instrumental to identify
the primary clinical efficacy endpoints and establish the duration of the clinical trial.

Public health relevance
PROJECT NARRATIVE Familial lecithin:cholesterol acyl transferase (LCAT) deficiency (FLD) and fish-eye disease (FED) are both rare hereditary conditions caused by pathogenic variants in the gene for LCAT, an enzyme involved in cholesterol metabolism. The two conditions share certain characteristics, such as markedly low HDL cholesterol levels, however FLD patients have a more variable and severe phenotype, including the early development of renal failure. Our study will provide the opportunity for a comprehensive characterization of patients with LCAT deficiency that is necessary for identifying biomarkers that can be used to predict patients at high risk for adverse disease outcomes and assess treatment efficacy in future clinical trials of novel therapeutics for LCAT deficiency.